Macrophage nuclear receptors, metabolism and immune effectors during health and M. tuberculosis infection- Diversity Supplement

PROJECT SUMMARY/ABSTRACT NOT REQUIRED PER PA-18-906

Public health relevance
PROJECT NARRATIVE NOT REQUIRED PER PA-18-906